Transcriptional Regulation of Cone Photoreceptor Genesis

PROJECT SUMMARY/ABSTRACT
Cone photoreceptors are the primary photoreceptor class that mediates high acuity and daylight vision. As
such, their loss during the course of human disease greatly impairs visual function. Cell-based therapies to
ameliorate these conditions have been proposed, in which introduction of new cones could replace those lost
to disease. These cells could be produced exogenously from sources such as stem cells or from resident, in
vivo populations such as Müller glia. For both strategies, it is necessary to develop new methods to specifically
promote cone formation, and to assess whether de novo formed cones are molecularly equivalent to those
formed during normal development. However, a significant gap exists in the current knowledge of gene regula-
tory networks that promote cone photoreceptor development. The long-term goal of this project is to identify
the gene regulatory networks active in cone genesis, and to devise methods based on this knowledge to gen-
erate new cone cells for cell replacement therapy. Recently, transcription factors with enriched expression in
early developing cones have been identified, yet the genetic requirement of these factors or how they interact
with one another to promote the cone fate is unknown. The central hypothesis of this proposal is that these
transcription factors are required for cone photoreceptor genesis and are part of a gene regulatory network
with defined regulatory interactions. The rationale to undertake these studies is that elucidation of the normal
genetic mechanisms of cone photoreceptor formation will inform the directed formation of cones from stem
cells or endogenous retinal cell populations such as Muller glia. Identification of the proteins that have im-
portant regulatory functions in cones will allow development of new cone induction protocols with greater and
more efficacious production of functional cones. To accomplish this goal, the following three aims are pro-
posed: 1) A functional analysis of early cone-enriched transcription factors, 2) Identification of key expression
and functional parameters of Sall1, a transcription factor involved in cone induction and rod repression, and 3)
Identification of Nrl cis-regulatory elements that repress Nrl expression in cones. The first aim will use an effi-
cient gene editing and single cell transcriptomic approach to determine the necessity of newly identified tran-
scription factors expressed in early stage cones. The second aim will investigate the endogenous role of Sall1
in cone formation and the extent to which expression of this gene is sufficient to induce cone transcriptional
programs. The third aim will identify the transcriptional mechanisms that prevent the rod-specific transcription
factor Nrl from being expressed in cones. This approach is innovative because it will investigate the early mo-
lecular events in cone formation using high-resolution and robust methods. Completion of the proposed project
will result in significant insights into the gene regulatory networks that promote cone formation and will inform
the development of rationally designed and effective methods to promote de novo cone formation.

Public health relevance
PROJECT NARRATIVE Cone photoreceptors are the critical photoreceptor class for daylight and high acuity vision, and loss of these cells in the course of human disease leads to a drastic reduction in visual capabilities. This proposal will identify key molecular elements that are critical for the early stages of cone formation, which will define new benchmarks and inform the generation of new strategies for the de novo formation of cone photoreceptors. This is expected to have a significant impact on the development of cell-based therapies for human blindness, and as such, is highly aligned with the mission of the National Eye Institute.